Community Engagement ane Outreach (CEO)

Community Engagement and Outreach Core Project Summary
High-quality clinical and translational research (CTR) improves public health by moving scientific innovations
from pre-clinical, to clinical, and, finally, to population health solutions that address priority health concerns
across the nation. The Community Engagement and Outreach (CEO) Core’s responsibility is to enable and
enhance CTR by facilitating collaboration among research, practice, and community stakeholders as they seek
to address and resolve regional health issues. This requires active engagement with clinical and community
systems that would ultimately adopt, implement, and sustain new research-developed innovations. The CEO
Core developed a number of community-engagement, team science, and outreach resources to ensure that
the work we do is relevant and fills the needs in rural and underserved populations in our region. Our aims
include activities and resources focused on 1) establishing regional health priorities and increasing capacity to
conduct community-engaged CTR to address these priorities, 2) facilitating the production of high-quality and
locally relevant community-engaged CTR, and 3) communicating and promoting network research findings,
project opportunities, and resource availability across member, community, Practice-based Research Network
(PBRN), and stakeholder groups. Innovative aspects of CEO include a Summer Institute for Community-
Engaged CTR for both researchers and community partners and a Community-Engaged Research Incubator
to support the development of large-scale CTR projects. CEO established a Community Advisory Board (CAB)
that includes representatives from across the region that our network serves with broad representation of
community organizations, healthcare, and public health. The CAB goals include the identification and
prioritization of regional health concerns, contributing to the review process for proposed Pilot and Scholar
applications, and helping distribute research findings to the communities we serve. In addition, CEO provides
resources for community members and investigators to stay up to date with network activities by accessing our
community-centered Community Conversations blog, event calendar, presentations, seminars, and Science
Cafes. The CEO also maintains a Clinical Trials portal, a Community-engaged Studies portal, a Community
Collaborators Registry, and CITI Training resource page. The CEO hosts seminars and workshops in
partnership with the Professional Development Core and other content Cores to provide the tools and training
that improve community-engagement practices and to help researchers understand and prioritize community
concerns that might be addressed with CTR projects. We will continue to make available on our website
recorded videos from our seminars/workshops. The Core supports a regional PBRN that works to merge
clinical practice with evidence-based research. Finally, CEO also provides services and consultations to help
CTR investigators engage community members and organizations while concurrently providing opportunities
for community members and organizations to better engage CTR researchers to address high-priority issues.